Cancer Research Training and Education Coordination

CANCER RESEARCH TRAINING AND EDUCATION COORDINATION CORE – ABSTRACT
The Cancer Research Training and Education Coordination Core (CRTEC) was established by Cancer Center
Director David Tuveson in 2019 to complement the rich intellectual research training environment at CSHL. The
Core is overseen by Deputy Director of Education and Diversity Lloyd Trotman and managed by Associate
Director of Administration and Education, Jaclyn Jansen with support from Stephanie Franco, Administrative
Assistant for Education and Diversity at CSHL. The Core provides consistent education and career development
for the more than 350 researchers in the Cancer Center, and also supports existing institutional efforts, including
programs to educate elementary and secondary level students, undergraduates, and the public. The CRTEC
Core efforts are broadly organized around three central themes: Scientific Enrichment; Career Progression and
Exploration; and Essential Professional Skills. The Core uses surveys and evaluations to guide workshops,
lectures, streamlined resources, and financial investments in each of these three focus areas. In its first year,
the Core ran 27 workshops/courses with more than 175 Cancer Center lab members registering to attend. The
efficacy of these programs is evaluated based on rigorous outcome data for both trainees and faculty. Cancer
Center graduate students and postdoctoral fellows have co-authored 157 papers, and there are 13 trainees in
the Cancer Center supported through NIH Institutional NRSA training grants and NIH and philanthropic career
development awards totaling more than $875,000. The CRTEC Core is supported by substantial coordination
and financial commitment from the Institution. The Core is currently in the early phase of these programs; initial
outcomes suggest that the above efforts are having a broad and significant impact on the training environment
in the Center. In the next five years, the Core will continue to expand its academic programming and streamline
data acquisition, while targeting efforts toward increased diversity at the Lab.

Public health relevance
CANCER RESEARCH TRAINING AND EDUCATION COORDINATION- PROJECT NARRATIVE Not required per PAR-20-043